PHASE I EVALUATION OF ORAL AND IV NAVELBINE IN PEDIATRIC CANCER PATIENTS

To determine the maximum tolerated dose of navelbine given by short IV infusion at weekly intervals in pediatric patients with previously treated leukemia, lymphoma, or solid tumors; to determine toxicities, pharmacokinetics, and antitumor activity of this drug within confines of Phase I study.